Immunoregulation in CNS remyelination

PROJECT SUMMARY
Failure to regenerate myelin in multiple sclerosis (MS) contributes to progressive axonal loss and
accumulated disability. We have found that the pharmacological inhibition of Slc7a5, a large
neutral amino acid transporter, significantly increases a cluster of microglia/macrophages
associated with regeneration in demyelinated lesions, leading to enhanced remyelination in mice.
How Slc7a5 inhibition influences microglial activity and impact the lesion microenvironment during
remyelination remains unknown. Here, we hypothesize that Slc7a5 inhibition shfits the activation
state of microglial cells in demyelinated lesions towards a pro-regenerative state, thereby
increasing oligodendrocyte differentiation and the remyelination process. To this end, we will
examine the impact of conditional Slc7a5 deletion in microglia and macrophages on
oligodendrocyte and microglia/macrophage responses during remyelination (Aim 1), examine the
metabolic and proteomic composition of pro-regenerative myeloid cells from demyelinated lesions
of mice under Slc7a5 loss-of-function (Aim 2), and examine candidate microglia/macrophage
expressed factors in in the regulation of remyelination under Slc7a5 deletion (Aim 3). The results
of this study will reveal new mechanisms of microglia-oligodendrocyte interaction during
remyelination, and potentially lead to new therapeutic strategies targeting microglial plasticity in
demyelinated lesions to improve remyelination in MS.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis (MS) is an immune-mediated neurological disorder characterized by the accumulation of lesions laden with inflammatory microglia in the central nervous system (CNS), which drive demyelination and impede the remyelination process. This project will investigate a strategy to enhance remyelination by genetically modifying microglial cells in demyelinated lesions towards a pro-regenerative state. The results of this study will advance our understanding of the immunoregulatory mechanisms governing remyelination, which could have implications for the development of pharmacological therapies aimed at improving remyelination in individuals with MS.